BLRD Research Career Scientist Award Application

Dr. Lau is an established expert in molecular genetics and transgenic mouse modeling of human diseases
and an internationally recognized investigator in the Y chromosome biology. He has a long history of
contributions to advances in the fields. He had generated a series of versatile cosmid vectors capable shuttling
between bacterial and mammalian cells, and constructed comprehensive human genome recombinant DNA
libraries that were distributed and used successfully in many laboratories worldwide in the 80s. He served as the
US Chair/Organizer in the International Workshops on the Y chromosome, responsible for establishing the
genetic and physical maps of the human Y chromosome in the 90s, forming parts of the foundation for the
complete sequencing of this chromosome in the Human Genome Project in 2000s. He had organized numerous
elite conferences, such as the Gordon Conferences, in his fields. He has installed advanced next generation
sequencing technologies and bioinformatics in the Molecular Core at the SFVA in the 2010s. He is presently
the Editor-in-Chief of a biomedical journal, Cell & Bioscience with impact factors of 7.5-9.6 in recent years. His
current research focuses on understanding the contributions of the Y chromosome genes, particularly the sex-
determining gene SRY and the putative proto-oncogene TSPY, in various sexually dimorphic diseases and
cancers using transgenic mouse modeling, molecular genetics and genomics strategies. Dr. Lau demonstrated
that SRY could competitively disrupt the gene regulation programs of related SRY-box (SOX) transcription
factors, thereby exerting male-specific influences in the affected tissues. He hypothesizes that at low levels SRY
could be responsible for various sex differences in the development and physiology normally observed between
the sexes. At high levels SRY could promote pathogenesis in sexually dimorphic diseases, such as Alzheimer's
disease. Using molecular genetics and transgenic modeling, Dr. Lau has provided evidence supporting his
hypothesis. TSPY was initially cloned in Dr. Lau’s laboratory. He showed that it is the gene for the
gonadoblastoma locus on the Y chromosome (GBY), predisposing the germ cells of XY females to
gonadoblastoma and other germ cell tumors. Importantly, TSPY binds to cyclin B-CDK1 and stimulates its kinase
activities, promotes G2/M transition and cell proliferation. TSPY interacts with and exacerbates the transactivation
activities of androgen receptor (AR) and constitutively active AR variants. TSPY is also a target of AR/AR variants,
thereby forming a positive feedback loop in synergistic amplifications of respective functions between a Y-
chromosome gene and male sex hormone receptors. Recently he showed that TSPY is a cancer/testis antigen
(CTA), normally expressed in germ cells of the testis, an immune privileged organ, and various cancers, such
as hepatocellular carcinoma (HCC), lung, bladder, colon and kidney cancers, under oncogenic conditions.
Because of their cancer-specific expression, many CTAs are proposed to be targets for immunotherapy. The
suitability of any CTA depends on its cell surface location, ability to elicit immune surveillance and elimination of
tumor cells. Since TSPY positivity is the highest in HCC, Dr. Lau has directed his research on this cancer, using
an oncogene-induced HCC mouse model. He showed that co-expression of TSPY resulted in significantly
smaller tumor in the mice. Subsequent studies demonstrated that TSPY was highly immunogenic, present on
the cell surface and elicited robust immune responses and elimination of the positive tumor cells from the host
animals. Importantly, immunization of a TSPY-based vaccine to positive mice further inhibited tumor growth and
prolonged the lives of these animals. Since liver cancer is 5 times higher among the Veterans than the American
public, these new findings are important and provide scientific supports for TSPY as a target for immunotherapy
in treatments of positive liver cancer. Thus, Dr. Lau is a key and contributing member of the SFVA. For the next
funding period, he will focus on identifying the mechanisms and developing translational applications of TSPY in
immunotherapy of liver cancer in both preclinical and clinical settings to improve the Health Care of the Veterans.

Public health relevance
Dr. Lau is a key and contributing member of the San Francisco VA Health Care System. He is a world authority in the genetics of the male-specific Y chromosome and an expert in molecular genetics and animal modeling of human diseases. He has developed a vigorous research program to investigate the contributions of this male- specific portion of the human genome to gender disparities in various cancers and diseases. He correlates the laboratory results to the clinical features and outcomes and identifies biomarkers for precise diagnosis and prognosis in liver cancer, cardiovascular and neurodegenerative diseases. His recent works showed that a Y- protein can invoke robust immune responses and killing of positive liver cancer cells. His preclinical studies could lead to clinical translation in immunotherapy to treat the highly prevalent liver cancer among the Veterans.